Beckman Optima A/I Analytical Ultracentrifuge (AUC)

PROJECT SUMMARY
Characterizing the sizes, shapes, and interactions of biomolecules is a crucial prerequisite to understanding
biological function on a molecular level. Analytical ultracentrifugation (AUC) has been an essential component
of the biophysical tool kit for decades, exploiting the distinct optical and sedimentation properties of proteins,
nucleic acids, and polysaccharides to provide information on molecular structure and its changes. For
example, changes in the stoichiometry of a multimeric protein caused by small molecule binding, or the
addition of a partner protein, can be quickly and accurately quantified by changes in sedimentation properties.
AUC measurements are made in a matrix-free solution, typically without the need for exogenous labels, more
accurately capturing biological context than many other techniques commonly used to measure binding. AUC
analysis does not destroy nor dilute precious samples, making them fully recoverable for additional
downstream analyses. Over the past two decades, major advancements in AUC design now enable more rapid
detection of more complex molecular assemblies using a large number of wavelengths for absorbance
measurements. This proposal, in response to Program Announcement PAR-22-081, requests funds to
purchase a state-of-the-art Beckman Coulter Optima A/I AUC to advance the research goals of University of
Notre Dame’s NIH-funded scientists and engineers. This instrument will replace Notre Dame’s current
Beckman Coulter ProteomeLab XL-I AUC, the only AUC broadly available within a 90-mile radius of Notre
Dame. Despite careful maintenance and support over its lifetime at Notre Dame, the ProteomeLab AUC has
been plagued by numerous malfunctions over the past year. Crucially, the ProteomeLab AUC will no longer be
eligible for Beckman service support after 2025 and, at 18 years old, is optically and mechanically inadequate
to modern instruments. The new AUC will be housed in a recently renovated and expanded core facility; its
acquisition is an important piece of a large effort currently underway to expand and improve research
infrastructure at the University of Notre Dame. As such, supervision, care, and maintenance of this instrument
will contribute to employment stability for core facility staff, while access to this state-of-the-art research
equipment will continue to grow the scope and scale of research at Notre Dame.

Public health relevance
PROJECT NARRATIVE The sedimentation of many biomolecules during centrifugation produces a characteristic signature that contains valuable information on the three-dimensional structure of the biomolecule and its interactions with other biomolecules. Purchase of the proposed analytical ultracentrifuge (AUC) will enable University of Notre Dame researchers to accurately measure these sedimentation properties, as part of a broader effort to understand the molecular details of a wide variety of biological processes, including protein folding and aggregation, bacterial pathogenesis, and cancer mechanisms. AUC is a valuable biophysical method for the characterization of biomolecules, and crucial to advance Notre Dame NIH-funded research projects.